Input encoding in T-cell receptor signaling

ABSTRACT Signal sensing circuits in cells often perform at a level that rivals or even exceeds that of man-made detection devices. Understanding how these circuits perform optimally and robustly in a noisy cellular environment will yield fundamental insights into their underlying design principles, and will enable us to re-purpose these circuits for cell engineering. The signaling circuit that mediates antigen detection by T-cells exhibits particularly striking sensing capabilities — it can selectively respond to even a few copies of antigenic ligand, while retaining an ability to distinguish ligand levels over a five order of magnitude range. How T-cell receptor signaling circuits can achieve such remarkable selectivity, sensitivity and dynamic range in their operation is not understood. To address this question, we have developed a novel multi-pathway fluorescent reporter system that enables, for the first time, simultaneous live tracking of the activity of the three primary signaling pathways downstream of the T-cell receptor at the single-cell level. Here, we combine this multi-pathway reporter with quantitative live- cell imaging, mathematical modeling and perturbation analysis to elucidate the control strategies underlying T- cell ligand sensing, and determine how they are disrupted in T-cell dysfunction. Firstly, we will (I) perform a systematic, quantitative characterization of input/output responses of individual pathways and T-cell receptor engagement. This characterization will be performed at the single-cell level, using a combination of high throughput live imaging and computational image analysis. Next, we will (II) elucidate regulatory feedback loops underlying these responses. To do so, we will perform mathematical modeling of candidate feedback architectures, followed by iterative experimental testing. Finally, we will (III) determine how these input/output states are perturbed upon T-cell dysfunction, using live-cell imaging techniques in conjunction with mouse models. These studies will generate fundamental insights into antigen sensing mechanisms by T-cells, yielding guiding principles for engineering T-cells to treat cancer and other diseases. More broadly, this work will also elucidate principles underlying architecture and design of mammalian signaling circuits, impacting systems and signaling biology studies across diverse fields.

Public health relevance
NARRATIVE We aim to understand how signal sensing circuits present in T-cells allow them to precisely detect and destroy cancer cells and virally infected cells in our body. These results will help us better engineer therapeutic T-cells for the treatment of cancer and other diseases.